Boston Collaborative for TMD Research

The Boston Collaborative for Temporomandibular Disorders (BCTMD) consists of preexisting,
interrelated components which currently function within the Massachusetts General Hospital
(MGH), Harvard School of Dental Medicine (HSDM), and Tufts University School of Dental
Medicine (TUSDM). The BCTMD collaborative consist of a robust clinical practice - Orofacial Pain
(OFP) and Temporomandibular Joint (TMJ) surgery, a research collaborative where the group
has developed several evidence-based local registries, a large data bank of TMJ synovial and
joint biopsies, a regenerative medicine laboratory focused on cellular and molecular TMJ
research, community outreach programs, and training programs students, research fellows and
practicing clinicians. The goal of the BCTMD is to understand TMJ patient needs, the gaps in
dental school curricula in TMD, gaps in healthcare delivery affecting access to care, the need for
further basic and applied research to advance our knowledge of TMJ disease, and to ensure that
TMD services, both diagnostic and treatment, are the right ones for each patient, and are proven
to be safe, accurate and effective. The BCTMD intends to achieve these goals by working within
a national framework of TMD IMPACT stakeholders to elucidate these barriers, develop national
registries for a better understanding of our patients and disease processes, target treatment
strategies through basic and clinical research, enhance translation of evidence-based findings to
clinical care, and lastly, use this national TMD IMPACT framework to train the future generation
of researchers and clinicians. Implementation of these main goals of the collaborative requires
infrastructure, a team of clinicians, researchers, educators as well as resources and BCTMD is
perfectly positioned to meet these goals. The TMD IMPACT study will be a 5-year study. Our
goals for Year 1 will be 1. To build collaborations nationally through scientific meetings, form a
central Executive Committee and establish priorities for research. 2. Present these findings at
national meetings and generate publications 3. Planning infrastructure for development of
evidence based national patient registries for implementing data sharing, coordination,
harmonization and interoperability within the TMD IMPACT 4. Fortify the education and CE
programs with previously identified collaborators. The next four years will be used in implementing
these nationwide registries, developing tools for enhancing clinical and basic science research
using these registries, developing curriculum for TMD training, increasing community outreach,
and participation of patient advocacy groups.

Public health relevance
Project Narrative Our members enthusiastically look forward to working within a national Collaborative to reach our common goals and the most important goal is the effective training of the next generation of TMD researchers. This result can be reached from the establishment of a national collaborative framework based on the utilization of specific diagnostic criteria to identify heterogenous cohorts of TMD patients from national registries of subjects and data repositories from such subjects. We then can confidently translate research findings into evidenced-base interprofessional care of TMDs.